EFFECT OF INFANT POSITION ON IMPEDANCE/STRAIN GUAGE BREATH AMPLITUDE

Infants will be monitored with two types of apnea monitors to study the effect of change in infant positioning on measurement of breath amplitude to determine to what cause to attribute the change in signal.